Pregnancy induced deacetylation of sialylated glycoproteins

Pregnancy induced deacetylation of sialylated glycoproteins
Abstract. Pregnancy confers susceptibility to severe infection caused by intracellular pathogens, including the
prototypical perinatal bacterial pathogen, Listeria monocytogenes (Lm). Residence inside cells has traditionally
been thought to be exploited by microbes to evade antibody-mediated immunity since IgG cannot cross the
plasma membrane and directly enter cells. Our ongoing studies challenge this paradigm by showing vertically
transferred maternal IgG antibodies efficiently protect neonates against Lm infection. The key molecular
change enabling protection is deacetylation of terminal sialic acid residues in glycosylated anti-Lm IgG.
Expression of the deacetylating enzyme sialic acid acetyl esterase (SIAE) increases during pregnancy. This
enzyme is essential since anti-Lm antibodies in SIAE-deficient pregnant mice remain acetylated, and non-
protective upon vertical transfer into neonates. Sialylated glycoproteins normally stimulate host cells by binding
CD22, an inhibitory Siglec expressed by B cells. However, acetylation blocks CD22 binding, establishing the
framework whereby differential acetylation versus deacetylation of sialylated IgG and other glycoproteins can
profoundly impact immunity through CD22 binding, which in turn, controls activation and immune-modulatory
function of B cells and other cell types with regulatory potential. Although these results significantly broaden
the scope for how antibodies work, they also unveil important new knowledge gaps on whether deacetylated
IgG similarly protects against infection outside the neonatal window, including during pregnancy with similarly
increased susceptibility to Lm systemic infection, and after parturition when deacylated antibodies are still
present at high levels. Other questions include the maternal cell types expressing SIAE responsible for
antibody protective conversion, and the larger impacts on fetal tolerance and pregnancy outcomes controlled
by deacetylation considering many fetal alloantigenic glycoproteins also contain sialylated N-linked glycans.
Our overall hypothesis is that SIAE deacetylation unmasks a variety of sialylated glycoproteins as new CD22
ligands, which differentially modulate the suppressive properties of maternal immune cells, with context-
dependent impacts on infection susceptibility and pregnancy outcomes. Shared susceptibility to Lm infection
during pregnancy in humans and rodents will be exploited to further investigate how deacetylated antibodies
work, in concert with fetal alloantigenic glycoproteins, through the following specific aims: Aim 1, determine
whether deacetylated IgG protects against Lm systemic infection during pregnancy and after parturition; Aim 2,
establish the SIAE-expressing maternal cell subset(s) responsible for IgG protective conversion; Aim 3,
investigate how SIAE exposed CD22 ligands control fetal tolerance and pregnancy outcomes. Completion of
these aims will not only unveil important insights as to how antibodies protect against intracellular infection, but
also new information on the immune-pathogenesis of fetal wastage that occurs with Lm prenatal infection and
exciting ways for boosting antimicrobial immunity in this vulnerable physiological window.

Public health relevance
Public Health Relevance. Pregnancy confers unique susceptibility to infection by Listeria monocytogenes and other pathogens that primarily reside inside cells, as a means to evade protection by antibodies. We recently showed deacetylation of glycosylated antibodies expands their protective scope to intracellular infection, and this application will further investigate how pregnancy-modified antibody protect against perinatal infection.